ShootSafe: An interactive web platform to teach children hunting, shooting and firearms safety

ShootSafe: An Interactive Website to Teach Children Firearms Safety
Firearms injuries present a major pediatric public health challenge to our country, killing over 800
children ages 0-15 annually and leading to lifelong disability among over 1000 survivors. About ⅓ of firearms
injuries to children under age 15 are due to unintentional causes rather than suicide or homicide. We propose
development and evaluation of ShootSafe, an innovative, engaging, and educational website accessible by
smartphone, tablet or computer that engages children to learn firearms safety.
ShootSafe extends a smattering of existing basic programs to achieve three primary educational goals:
(a) teach children the knowledge and skills they need to hunt, shoot, and use firearms safely; (b) help children
learn and hone the critical cognitive skills of impulse control and hypothetical thinking needed to use firearms
safely; and (c) alter children's perceptions about their own vulnerability and susceptibility to firearms-related
injuries, the severity of those injuries, and their perceived norms about peer behavior surrounding firearms use.
ShootSafe will accomplish these goals through a combination of interactive games and activities plus powerful
podcast videos delivered by peer actors (impactful testimonials about firearms injuries and deaths they
experienced) and experts (wisdom and experience from trusted role models). The website will deliver
messages through the internet, a technological medium today's children prefer learning in. It also will
incorporate brief messaging to parents, who will absorb key lessons and reinforce them with their children.
The project has two specific aims: (a) develop an innovative and engaging website to train children in
firearms safety and (b) evaluate the website through a randomized controlled trial with 162 children ages 10-
12, randomly assigning the children to engage in the ShootSafe website or an active control website on child
nutrition. The second aim will incorporate sub-aims to evaluate changes in children's (a) knowledge, (b)
cognitive skills in impulse control and hypothetical thinking, (c) perceptions about firearms safety, and (d)
simulated behavior when handling, storing and transporting firearms. All outcome measures will be assessed
through multiple methods and measures at baseline, immediately post-intervention, and at a 4-month follow-up
assessment to evaluate retention. Training will comprise two 30-minute sessions.
In summary, we propose a program that addresses a critical pediatric public health problem through an
electronic platform that appeals to today's children and innovative programming to deliver basic knowledge
about firearms safety, hone relevant cognitive skills, and alter perceptions about safety. If the study hypotheses
prove true, translation into practice through broad dissemination is highly feasible.
Note that this project falls under Objective Two in the RFA (to rigorously evaluate effectiveness of an
innovative and promising strategy to keep individuals safe from firearm-related injuries and death). It also falls
under Funding Option B, as it will support new data collection activities.

Public health relevance
Narrative Firearms-related injuries are a leading cause of pediatric morbidity and mortality in our country. This project will develop and then evaluate a website designed to teach children how to engage safely with firearms. Results will have significant implications for improving public health by reducing unintentional pediatric firearms-related injuries and deaths.